Reelin Signaling and Function in Cocaine Response

Psychostimulant abuse is a public health crisis that affects millions of individuals in the United States and
results in profound economic, social, and individual harm. However, despite rapid increases in overdose
deaths linked to stimulant drugs like cocaine, there are still no approved therapeutic options for stimulant
abuse disorders. Psychostimulant drugs act through well-defined signaling mechanisms to elevate
dopaminergic neurotransmission in the nucleus accumbens (NAc), a key reward-linked brain structure that
integrates information from diverse brain regions to directly influence motivated behavior. Further, cocaine
causes epigenetic and transcriptional reorganization in medium spiny neurons (MSNs) in the NAc, promoting
maladaptive shifts in cell signaling and synaptic function. Our preliminary data indicates that expression of Reln
mRNA, which codes for the large secreted extracellular matrix protein Reelin, is enriched in a subpopulation of
MSNs that are robustly activated by cocaine. Although Reelin knockout animals exhibit impaired response to
psychostimulants and Reelin plays a critical role in synaptic plasticity and memory formation in other brain
regions, the role of Reelin in cocaine-related cellular and behavioral adaptations has never been studied. In
this proposal, we will test the overarching hypothesis that Reelin signaling is required for the maladaptive
molecular, physiological, and behavioral effects of cocaine in the NAc. Specific Aim 1 of this proposal will
combine bidirectional CRISPR-based manipulations and single-cell RNA sequencing to determine how Reelin
signaling impacts transcriptional responses to cocaine and dopamine receptor activation. Specific Aim 2 will
use in vitro and in vivo single unit recordings and ex vivo slice electrophysiology to test the hypothesis that
Reelin regulates cocaine response by modulation of physiological and synaptic properties of MSNs. Finally,
Specific Aim 3 will use cell-specific in vivo Reelin manipulations in combination with behavioral assays of
cocaine and natural reward to test the hypothesis that Reelin enhances the behavioral effects of cocaine.
Together, these experiments will identify Reelin target genes in the NAc, dissect molecular signaling pathways
by which Reelin alters MSN function and physiology, and determine whether Reelin expression within the NAc
modulates cocaine-related behavioral plasticity. These studies will reveal fundamental mechanisms by which
Reelin contributes to psychostimulant response, and will pave the way for future experiments to explore how
this unique Reln-expressing cell population contributes to motivated behavior.

Public health relevance
Drugs of abuse activate specific cell populations within brain reward circuits, but it is not clear what molecular mechanisms regulate this process or how drug experience can result in long-lasting changes within these cells. This proposal will examine the role of Reelin, a large extracellular protein, in regulation of the molecular and genetic mechanisms that contribute to cellular and behavioral responses to cocaine. This research will contribute fundamental knowledge to our understanding of how brain circuits drive motivated behaviors in the context of substance abuse disorders, and has the potential to identify novel cellular targets for addiction therapeutics.